After the Dust Settles: Changes in Local Healthcare Access and Utilization after Civil Unrest

Project Summary
In recent years, police violence has become a more visible occurrence in American society, largely due
to the fast-paced availability of information and footage via social media.1 The resulting civil unrest following
these events represents a form of structural violence with profound implications for marginalized communities.
This violence leads to lasting effects on health through disruptions to education, transportation, economic
opportunities, and other social determinants of health. The overarching goal of the proposed research is to
examine connections between forms of structural racism and healthcare access, quality, and outcomes. The
immediate goal of this dissertation proposal is to analyze the impact of civil unrest on long-term healthcare
utilization and mental healthcare utilization for older adults in affected communities. We hypothesize that civil
unrest events will increase preventable hospitalizations, emergency department (ED) visits, decrease primary
care visits, and raise the volume of mental health visits related to anxiety and depression.
The specific aims are to: (1) Evaluate the impact of civil unrest, following incidents of police violence, on
healthcare utilization, specifically focusing on preventable hospitalizations, emergency department (ED) visits,
and primary care visits, and (2) Analyze sustained changes in the volume of mental health visits related to
anxiety and depression within communities affected by civil unrest. Our proposal will include older adults
enrolled in traditional fee-for-service Medicare in Minneapolis, Minnesota, Baltimore, Maryland, and Ferguson,
Missouri, whose healthcare utilization will be tracked 6 months before and 24 to 36 months following incidents
of unrest related to police violence. Using a quasi-experimental econometric design, we will compare
healthcare utilization between Black and white beneficiaries within these regions before and after incidents of
civil unrest. This approach is innovative because it uses sophisticated models to longitudinally analyze the
impact of structural racism on healthcare at the regional level, rather than nationally. Previous research on
structural racism and its relationship to health outcomes is limited to measures related to socioeconomic
status, health system quality, and more, but not structural violence, such as police brutality and civil unrest.
This proposal is the first analysis to use Medicare claims to examine if there is a relationship between
structural racism and healthcare utilization through localized incidents of unrest. This dissertation proposal is
significant because it is a direct response to the NIA's scientific priority of understanding “health disparities
related to aging and develop strategies to improve the health status of older adults in diverse populations.”2 We
expect this analysis to highlight the nuanced relationship between structural racism and healthcare utilization
among traditional fee-for-service Medicare beneficiaries. Though the results will be specific to the isolated
incidents at the community level, the findings will have salient implications for future racial health equity
research.

Public health relevance
Project Narrative This proposal is relevant to long-term services and supports because civil unrest could have a substantial impact on the way Medicare beneficiaries utilize healthcare in the long term. Examining a relationship between incidents of civil unrest and healthcare access and utilization could impact the overall health of marginalized communities because understanding changes to utilization and access, such as civil unrest, could inform programming and craft policies that improve the health and well-being of vulnerable populations. The proposal aligns with the National Institute of Aging’s mission of conducting research to extend healthy, active years of living by assessing changes in healthcare access and utilization.